Examining the Association Between Sleep Deficiencies and Suicidal Ideation in Peripubertal Youth Receiving Intensive Psychiatric Services: A Multi-Modal Approach

PROJECT SUMMARY
Suicide rates among peripubertal youth have tripled in the last decade, and suicide is the second leading
cause of death for adolescents. Despite alarming increases in preadolescent suicide, little is known about the
day-to-day dynamics of suicide risk, especially among pre-adolescent youth experiencing severe stress and
psychopathology. One factor unique to this developmental stage that could explain why suicidal thoughts and
behaviors (STB) increase dramatically is sleep disruption. Peripuberty is uniquely sensitive to poor sleep
health, and research suggests that suicide risk during adolescence coincides with changes in sleep-wake and
circadian regulation. However, despite evidence supporting both sleep and STB being dynamic and
development processes, almost all research to date has focused on adults and used retrospective or long
follow-up periods. which substantially limits the clinical translation of research to this vulnerable population. We
propose to examine the dynamic influence of sleep deficiencies (e.g., insufficient duration, irregular timing,
poor quality) on next-day suicidal ideation (SI) in a high-risk peripubertal youth population. We will examine
three domains of sleep deficiencies using subjective daily diaries and objective passive wrist-based actigraphy
and heart rate. We will also explore the influence of potential confounding or amplifying factors, including
depressive symptoms severity, pubertal stage, sex, and childhood adversity exposure. We aim to overcome
the limitations of previous research by using (1) a high-risk sample of peripubertal youth (ages 9-12), (2) a
multi-model assessment of sleep deficiencies, and (3) a 30-day daily diary (N = 150) and passive actigraphy
assessment (n = 50) of sleep. We hypothesize that shorter sleep duration, lower quality, and later or more
variable timing will longitudinally predict heightened next-day SI. This will be the first study examining sleep
deficiencies and prospective SI within peripubertal youth. Findings have a high potential to impact our
understanding of early risk identification and, ultimately, the prevention of the dramatic escalation in STB risk
from childhood to adolescence. Additionally, this proposed project will be instrumental to the Applicant’s
professional trajectory and long-term goals of pursuing a clinical research career in a medical center setting.

Public health relevance
PROJECT NARRATIVE Suicide rates in adolescents and children younger than 14 have increased in the past few years. Although it is well known that sleep deficiencies are risk factors for suicide, these mechanisms are not well established in peripuberty. This proposal addresses this gap by utilizing multi-modal and longitudinal methods to assess the association between sleep deficiencies and prospective suicidal ideation in this unique developmental period.